Exploiting Pathogen-Encoded Immune Evasion Proteins to Uncover Evolutionarily Conserved Antiviral Host Machinery

Project Summary
Virus-host interactions drive a remarkable diversity of host immune responses and viral countermeasures
during host-pathogen coevolution. Identifying and characterizing virus-host interactions within this evolutionary
“arms race” is critical for understanding how the outcome of these interactions favor either productive pathogen
replication or abortive infection. Furthermore, if one can identify pathogen-encoded immune evasion proteins
(IEPs), they might be exploited to discover and probe the cellular machinery they target. We are developing new
approaches to identify IEPs that target conserved eukaryotic machinery and are capable of tipping the balance
between abortive and productive viral infection. While classical approaches have employed virus-host models
wherein the virus can productively infect the chosen host, we have developed a new paradigm that exploits
naturally abortive arbovirus infections in lepidopteran (moth and butterfly) cells as a screening tool to identify
novel IEPs encoded by mammalian pathogens that convert abortive infections to productive infections by
countering host immune responses. By identifying IEPs encoded by mammalian pathogens that retain
immunosuppressive function in insect cells, we can select for IEPs that target antiviral machinery conserved
between invertebrate and vertebrate hosts. Using this approach, we have identified several IEPs encoded by
mammalian pathogens that target conserved host machinery that we have subsequently found to perform
antiviral functions. For example, one current area of focus is the characterization of poxvirus-encoded A51R
proteins as a new family of mammalian IEPs that target the facilitates chromatin transcription (FACT) complex,
an evolutionarily-conserved histone chaperone complex, that inhibits cytoplasmic virus replication in insect and
human cells. Using A51R proteins to probe FACT functions, we discovered that a post-translationally modified
form of a FACT complex subunit is bound by A51R proteins and mislocalized to the cytoplasm during poxvirus
infection. We also found several, unrelated RNA viruses to encode IEPs that prevent and/or reverse FACT
subunit modification. Using virological, genetic, and biochemical approaches, we aim to reveal how viral IEPs
impede FACT complex activity, the role of FACT in determining host susceptibility to infection, and the function(s)
of FACT subunit post-translational modification in both antiviral and normal cellular processes. Finally, we are
developing a pipeline to exploit our arbovirus-lepidopteran host system to identify additional IEPs targeting
conserved host factors that act as key determinants of intracellular pathogen restriction. Using this pipeline, we
identified ~10 IEPs encoded by bacterial pathogens infecting mammals that relieve arbovirus restriction in insect
cells, suggesting these IEPs target host defenses that broadly restrict viruses and bacteria. Our overall mission
is to identify novel IEPs encoded by mammalian pathogens in our unique system and use them to provide
mechanistic insights into the antiviral (and normal) functions of the conserved host machinery they manipulate.

Public health relevance
Project Narrative Viral infections continue to pose significant economic and public health challenges worldwide, yet we still only poorly-understand the host defenses that inhibit viral replication and the immune evasion proteins (IEPs) employed by viruses to counter these host responses. Here we take a unique approach to identify IEPs encoded by mammalian pathogens that target evolutionarily-conserved antiviral host machinery by screening for IEPs that suppress antiviral immune responses in both insect and human cells. We will use these pathogen-encoded IEPs to identify and characterize the conserved host machinery they target and ultimately leverage this information to develop new strategies to defeat IEP function and block viral infection.